Effect of Sneathia vaginalis on the amnion

PROJECT SUMMARY:
Sneathia vaginalis (Sv) is emerging as a pathogen that is significantly associated with preterm birth and preterm
premature rupture of membranes. Due to its fastidious nature, it has only recently been recognized as a pathogen
through the use of DNA-based methods. Because it has historically been under-recognized, the biology and the
pathogenesis of S. vaginalis remain almost entirely uncharacterized. We have substantial evidence supporting
that S. vaginalis damages host tissues, and damage to the amnion could play a causative role in preterm
premature rupture of membranes. The goal of this application is to lay the foundation to characterize the damage
that S. vaginalis causes to the cellular and acellular components of amnion and the effect that it has on the
mechanical properties of amnion as a whole. To achieve this goal, we will delineate the time and dose
dependance of damage inflicted by S. vaginalis on mitochondria and microtubules and define the type of cell
death that exposure to the bacteria causes in Aim 1. In Aim 2, we will perform proteomics on proteins released
from untreated and S. vaginalis-treated amnion to detect changes both in proteins secreted by the cellular
components of amnion as well as changes in the integrity of the extracellular matrix components of the amnion.
In Aim 3, we will quantitatively assess the mechanical properties of amnion and the effects that S. vaginalis has
on those properties.

Public health relevance
PROJECT NARRATIVE: Sneathia vaginalis is very difficult to culture and detect; however, contemporary culture-independent techniques have recently elucidated it as an invasive pathogen capable of causing amnionitis and sepsis in mothers and neonates and it is strongly associated with preterm birth and preterm premature rupture of membranes. Through this project, we will study the damage that this pathogen inflicts upon the amnion. This addresses the NIH Healthy People 2030 Objective: “Reduce preterm births — MICH-07” and the Overarching Goal “Eliminate health disparities, achieve health equity, and attain health literacy to improve the health and well-being of all.”